Artificial thymic organoid platform to study T cell development and HIV/SIV infection using SIV/macaque model of HIV/AIDS

PROJECT SUMMARY
Functional CD4+ T lymphocytes are progressively lost during HIV/Simian Immunodeficiency Virus (SIV) infection
and must be continuously replaced. Hematopoietic stem cells (HSCs) are critically important in replenishing T
lymphocytes. However, bone marrow dysplasia and HSC dysfunction have been reported in HIV/SIV infection.
Surprisingly, a detailed understanding of the impact of HSC dysfunction on T cell generation and their
characteristics is elusive. Systematic study of the onset of HSC dysfunction and its impact on immune potential
in humans is hampered by infrequent bone marrow sample availability at desired stages of infection. This is
further complicated by the lack of an in-vivo system to track T-cell generation from bone-marrow-derived HSCs.
Furthermore, a direct viral infection of HSC and distinct thymocyte precursors has been reported. However, these
reports are conflicting and lack robust validation. Consistently, productive infection of thymic precursors and their
potential contribution to the establishment of latent viral reservoirs is ill-defined. These limitations warrant the
development of a system for systematic investigation of HSC dysfunction, its functional consequences on T cell
regenerative potential, and their infection. Encouragingly, recent advancements in the thymic organoid culture
systems have opened novel possibilities for supporting reproducible and efficient ex-vivo T cell generation from
tissue specific-HSCs. This combined with the feasibility of the SIV/NHP model for easy access to the bone
marrow and other significant tissue sources of HSCs at the desired stage of SIV infection has opened
unprecedented opportunities for HIV/SIV research. Therefore, here we propose to exploit a highly efficient,
serum-free, ex-vivo thymic organoid system and utilize the SIV/macaque model of HIV/AIDS to systematically
investigate the impact of HSC dysfunction on distinct thymocyte population characteristics and their infection. In
this direction, we have successfully established a novel ex-vivo nonhuman primate artificial thymic organoid
(nhpATO) model supporting efficient T cell positive selection via established early T cell thymocyte precursor
intermediates. Using these systems, we will first perform an in-depth investigation into the HSC dysfunction and
its impact on distinct thymocyte population characteristics (Aim 1). In this direction, we will define the stage of
the onset of HSC dysfunction, its impact on the kinetics of distinct thymocyte generation, and its impact on other
key properties such as TCR-dependent function. Next, we will investigate the host and viral determinants of HSC
dysfunction and transcriptional regulation promoting thymopoiesis (Aim 2). Finally, we will investigate the SIV
infection of thymic precursors and its potential to establish latent viral reservoirs (Aim 3). Thus, the SIV/NHP
model combined with the nhpATO system offers unique opportunities to address key questions and fill critical
knowledge gaps likely opening novel avenues for future HIV cure efforts using the SIV/NHP model. Moreover,
the novel thymic organoid platform of SIV infection established here will have important implications for screening
anti-viral therapeutics. The data generated from this study will significantly contribute to future NIH R01 grants.

Public health relevance
PROJECT NARRATIVE Dysfunctional T cells and persistent viral reservoirs are leading causes of failure to HIV/SIV cure. A system to reliably study early T cell generation and their infection is lacking. The proposed work will establish an innovative organoid system in the SIV/NHP model to study T cell generation, infection, and reservoir establishment.